Experimental Pathology Research Laboratory Shared Resource

Abstract/Project Summary
Experimental Pathology Shared Resource (ExpPath)
The mission of the Experimental Pathology Shared Resource (ExpPath) is to provide quality-
controlled, consistent, reliable, and cost-effective services for the histopathologic analysis of
human tumors and experimental animal cancer models. Every year, over 60 Perlmutter Cancer
Center (PCC) principal investigators, ranging from starting faculty to Howard Hughes
investigators, utilize ExpPath, which has been supported by our CCSG since its inception.
Since 2005 the lab has expanded the service portfolio significantly in the areas of biomarker
assays and tissue imaging. Under the direction of Dr. Cynthia Loomis, ExpPath serves as a
central hub in the workflow of tissue-based translational research, uniquely positioned as a
“bridge” between the wet-bench research laboratory and the clinic. It achieves its mission by
means of four Specific Aims: Aim 1) To assist PCC investigators in the molecular and
morphologic characterization of normal and diseased tissues by providing relevant scientific
expertise and technical support; Aim 2) To train investigators in tissue preparation, biomarker
detection and analysis; Aim 3) To introduce cutting-edge technology and novel approaches for
in situ interrogation of intact tissues; and Aim 4) To expedite translational research involving
clinical investigators and basic scientists with shared biomedical interests.